HEAL Clinical Coordinating Resource Center for the Pain Management Effectiveness Research Network

ABSTRACT
The Helping to End Addiction Long-term (HEAL) initiative was developed to identify scientific
solutions to the national opioid public health crisis as quickly as possible. As part of this
initiative, the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN)
will provide scientific guidance and coordination of the HEAL Pain ERN Trials. Specifically, the
Duke Clinical Research Institute (DCRI), the University of Utah, and Johns Hopkins/Tufts will
continue to provide integrated functions for the clinical resource coordinating center (CRCC),
data coordination resource center (DCRC), and the statistical and safety resource center
(SSRC) for the HEAL Pain ERN. The DCRI will provide clinical trial leadership and expertise,
assistance in study and protocol design, study implementation, and management, in
collaboration with the other HEAL ERN Resource Centers, for existing and new HEAL ERN
trials. The DCRI will serve as the CCRC for existing and new HEAL ERN trials.

Public health relevance
PROJECT NARRATIVE The Helping to End Addiction Long-term (HEAL) initiative is a trans-agency effort to find scientific solutions to the national opioid crisis. As part of this initiative, the Duke Clinical Research Institute (DCRI) will function as the Clinical Coordinating Resource Center (CCRC) and work with University of Utah and Johns Hopkins/Tufts to provide integrated scientific guidance, coordination, and execution of trials for the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN).